Core C: Biostatistics and Bioinformatics Core

PROJECT SUMMARY/ABSTRACT of the Biostatistics and Bioinformatics Core (BBC)
The Translational Research Program in Colorectal Cancer Disparities (TRPCD) SPORE will utilize cutting-
edge technologies to develop novel approaches for prevention, early detection, diagnosis, and treatment
aimed toward reducing racial and ethnic disparities in colorectal cancer (CRC) incidence and mortality. The
Biostatistics and Bioinformatics Core (BBC) will play a crucial role in deepening our understanding of these
disparities by using systematic and unbiased approaches. These will involve properly conducting research at
all phases, including study design considerations (e.g., common designs and protocols across study sites and
racial and ethnic groups), data collection methods (e.g., assays performed simultaneously), and data analyses
(e.g., accounting for factors that may confound the associations). To serve the SPORE program and ensure
the rigor of research activities, the BBC has two aims. Aim 1 is to provide statistical and bioinformatic support
in the areas of risk prediction, observational studies, survivorship, treatment response, and clinical trials,
utilizing a variety of cutting-edge omics data, such as single cell ATACseq and RNAseq, genome-wide genetic
sequencing, digital spatial single cell profiling, and microbiome profiling. The BBC will collaborate with SPORE
investigators on study design, data quality control, analysis, and interpretation of results, including biological
interpretation of study findings using bioinformatics tools. Additionally, the BBC will partner with all projects as
they prepare manuscripts and present their results to ensure that the data disseminated are unbiased and valid
across racial and ethnic groups. Aim 2 is to monitor ongoing methodological developments and evaluate state-
of-the-art statistical methods and computational tools as they are being developed to enable powerful analyses
of novel data structures arising from SPORE projects. When necessary, the BBC will also adapt existing or
develop new methods and tools to advance SPORE research. The BBC is fully integrated into the four SPORE
projects and the Career Enhancement and Developmental Research Programs, and has been designed and
structured specifically to support SPORE investigators and their translational cancer disparities research.
Together with the Administrative and Biospecimen and Pathology Cores, the BBC will synergistically interact
with investigators and provide statistical and bioinformatic support to ensure that study designs are unbiased,
data collection methods are consistently applied, and data processing and analyses are systematically
conducted across all racial and ethnic groups. The BBC investigators have extensive track records in
methodological and CRC research including germline genetics, tumor genomics, and translational research.
Building upon this record and established analytic expertise, the BBC will enhance the rigor and quality of all
TRPCD studies and help ensure that our SPORE successfully achieves its scientific goals.